Alveolar Septal Fibroblast Loss and The Pathogenesis of Emphysema

Commonly diagnosed among male US Veterans of advancing age and with prior history of cigarette smoking,
emphysema is a chronic lung disease in which loss of the alveolar-capillary gas exchange units ultimately leads
to end-stage respiratory insufficiency. Thus, understanding the mechanisms underlying lung function impairment
in emphysema and developing strategies to mitigate its development remains at the forefront of research into
US Veteran’s health.
Emphysema is associated with alveolar septal thinning, loss of extracellular matrix (ECM), especially elastin and
collagen, and alveolar simplification due to loss of alveolar epithelial cells, endothelial cells and fibroblasts. While
considerable attention has been focused on understanding how cigarette smoke (CS) exposure adversely
impacts alveolar epithelial cells and endothelial cells, little is known about its effect on alveolar septal fibroblasts,
which provide essential trophic and structural support to the alveolar epithelium. Using 2 validated mouse models
of emphysema, we have observed that PDGFRα+ alveolar fibroblasts are eliminated from alveolar walls and
septa prior to the pathologic development of airspace enlargement, raising the question of whether this event
may play a causal and previously unexplored role in emphysema. Therefore, the goal of this VA Merit Award
application is to test the hypothesis that emphysema is initiated by programmed cell death and loss of alveolar
fibroblasts, which in turn leads to loss of trophic support to the alveolar epithelium. Through the use of genetic
cell ablation and gain- and loss-of-function approaches in mice, we propose testing this hypothesis with three
Specific Aims. Aim 1 will test the hypothesis that alveolar wall and septal fibroblast programmed cell death
precedes the development of emphysema and leads to disrupted crosstalk with, and support to, alveolar
epithelial cells. This hypothesis will be tested by investigating which alveolar fibroblast subsets are lost during
emphysema development, when they are lost, the type of programmed cell death that occurs, and how their loss
functionally affects alveolar epithelial cells. Aim 2 will test the hypothesis that loss of alveolar fibroblasts is
sufficient to initiate the development of emphysema. This hypothesis will be tested using a conditional fibroblast
ablation strategy followed by assessment of the rate of alveolar epithelial cell loss and emphysema development.
The role of loss of specific alveolar fibroblast subsets in emphysema development will subsequently be
determined by conditionally ablating defined lung fibroblast subsets. Lastly, Aim 3 will test the hypothesis that
preventing alveolar fibroblast programmed cell death will maintain alveolar structural support and prevent
emphysema development. This hypothesis will be tested in two phases. First, we will investigate the mechanisms
of programmed cell death, with a focus on apoptosis and necroptosis. Second, based on this information, we will
conditionally express the anti-apoptotic gene, Bcl-2, or functionally inactivate the necroptosis pathway by
conditional RIPK3 or MLKL inactivation, in defined alveolar fibroblast subsets and determine the ability of the
mice to respond to cigarette smoke induced airspace enlargement. Although alveolar septal fibroblasts have
long been known to be positioned adjacent to, and in intimate contact with the alveolar epithelium, remarkably
little is known about how early fibroblast programmed cell death and functional loss may be necessary and/or
sufficient to promote the development of emphysema. The proposed studies will address this key knowledge
gap. Additionally, identifying methods to prevent alveolar fibroblast loss could lead to new opportunities to target
this process as a strategy to prevent emphysema development.

Public health relevance
Emphysema, a chronic and debilitating lung disease for which the primary risk factors are a prior history of cigarette smoking, male sex and advancing age, is commonly diagnosed in US Veterans. Histologically and functionally, emphysema is associated with loss of terminal lung alveoli which comprise alveolar epithelial cells, capillary endothelial cells and septal fibroblasts, the latter providing trophic and structural support to the alveolar epithelium. Little is known about the effects of cigarette smoke on fibroblasts or how this may affect the survival and function of the alveolar epithelium. This application seeks to address this fundamental knowledge gap and identify strategies to prevent lung tissue destruction in emphysema.